BYPASS ANGIOPLASTY REVASCULARIZATION INVESTIGATION (BARI)

The purpose of this study is to evaluate the long-term outcome of patients with multivessel coronary artery disease who underwent percutaneous transluminal coronary angioplasty (PTCA) or coronary artery bypass graft surgery (CABG) five years previous. Patients are utilizing the Clinical Research Unit for an extensive cardiac evaluation for the final clinical visit of the protocol.